Transgenic Mouse Model For Dermal Carcinogenesis

The major objectives of the project are to develop the TG.AC transgenic mouse model line (which carries a v-Ha-ras gene) as a model for (1) studying the multi-stage process of skin carcinogenesis: and (2) as a short -term (26 week) in vivo model for drug and chemical safety assessment and for prediction of the carcinogenic potential of chemicals. The induction of skin papillomas by repetitive topical application of a test chemical is considered to be the "reporter phenotype" that defines activity. But we and other laboratories have also demonstrated that other routes of administration, e.g., feed, water, oral gavage or I.P. injection are also appropriate for inducing tumors in the skin and other organm sites. Because of the chemical activity data base generated by LECM, the Tg.AC model has been accepted as a test component by the FDA for determining human risk assessment. The model detects both genotoxic and non- genotoxic carcinogens. Over 50 chemicals have been tested in the Tg.AC model to date. The results indicate that the model is most likely to detect trans-species carcinogens. A comphrehensive evaluation of transgenic mouse models for carcinogenesis assessment sponsored by the International Life Sciences Institute (ILSI) has recently been completed. The Tg.AC transgenic mouse model proved to be a conservative assay for detecting chemical carcinogens. Nearly all of the human carcinogens were detected, but most of the rodent carcinogens (identified in the conventional two-year bioassay) that were considered to be putative human noncarcinogens were inactive. Induced papilloma multiplicity (the reporter phenotype) has been shown to follow a reproducible dose-related pattern with such agents as benzene, TPA and TCDD. Thus Tg.AC mice are an appropriate model to evaluate the effects of diet, or the efficacy of anti-tumor agents or cocarcinogens that can modulate the tumor response. The exposure of Tg.AC mice to sodium arsenite in the drinking water significantly enhanced the multiplicity of TPA induced papaillomagenesis. The investigation of the role of early inflammatory or growth control response genes that associate with chemical or wound induced tumorigenesis in Tg.AC mice is continuing. The early induction of GM-CSF in the skin appears to be a requirement for TPA induced tumors. Injection of neutralizing antibodies to GM-CSF prior to TPA application significantly reduced tumor multiplicity, nearly to zero. Efforts are continuing to identify the key factors that activate the transgene in chemical and wound induced tumorigenesis.